Washington University PDX Development and Trial Center

The goal of the Pilot Projects and Trans-Network Activities Core is to support the development of research projects using PDX models that will advance the mission of the PDTC and PDXNet. The core will help to foster collaborative, translational research both within the PDTC and across the PDXNet by establishing two annual $50,000 awards. The goal of these supported projects will be to support the translational goals of the PDTC to advance translational research through the use of PDX models or, research methods to enhance experimental validation and reproducibility across PDTCs and the PDXNet. Pilot projects may support the development and integration of new technologies into the PDXNet program. Collaborative, PDXNet pilot projects may also be used for Cross-Network studies to establish best practice standards for research using PDX models. The Core will also engage non-PDXNet investigators, providing collaborative opportunities to use well-characterized PDX models that recapitulate human disease and further the reach of the NCI PDXNet program.

Public health relevance
Cancer is a complex and heterogenous disease that can arise from somatic and/or germline predispositional events in driver genes/pathways. Because of complex resistance and relapse mechanisms, combination therapies are generally viewed as necessary to improve the outcomes of patients with advanced malignancies. PDX models provide a platform for large-scale testing of combinations, allowing both identification of promising therapeutic regimens for future clinical trials and deeper investigation of the mechanisms governing therapy response and resistance.